Echoic Memory Function and Physiology in the Rhesus Macaque

7. PROJECT SUMMARY
Background. Echoic memory (EM) is a pre-categorical and passive form of auditory short-term memory.
EM is essential for processing sounds that are inherently fleeting yet acquire meaning only in relation other
sounds. The neural substrate of echoic memory has not bee identified. It is well-established that the
processing of a sound temporarily reduces the responsiveness of auditory cortex to similar sounds
(refractoriness or stimulus-specific adaptation: R/SSA). It has been noted that R/SSA fade with similar time-
constants as information about past sounds fades from EM. The proposed work will test the hypothesis that the
cause for the reduced responsiveness that underlies R/SSA is the neural substrate of EM.

Public health relevance
8. NARRATIVE Despite the importance of echoic memory for many aspects of auditory function, its neural substrate re- mains unknown. Here we will quantify key aspects of echoic memory in the non-human primate and compare its functional properties to several putative neural substrates in primary auditory cortex of the same animals. Identifying the neural correlate(s) of echoic memory will ultimately advance efforts to ameliorate echoic memory encoding deficits in schizophrenia.